Transgenerational Inheritance of a Cocaine Resistance Phenotype

Project Summary
The focus of this research program, which has been NIH-funded since 2012, is the influence of paternal
psychostimulant self-administration on the physiology and behavior of subsequent generations (i.e. offspring
and grand-offspring) using rat models. Our work previously demonstrated that sire cocaine self-administration
reprogramed the germline epigenome resulting in decreased cocaine reinforcing efficacy in the male progeny.
The current application expands our focus on cocaine alone to encompass the transgenerational effects of
paternal methamphetamine (meth), which will be compared and contrasted with cocaine. The proposed
research will examine the mechanisms whereby information is passed to meth-sired offspring (and potentially
grand-offspring) through epigenetic changes in sperm. We also will define epigenetic and transcriptional
profiles in the nucleus accumbens of cocaine- and meth-sired offspring that may underlie the respective
influences on psychostimulant self-administration. Specific Aim 1 will examine the behavioral consequences of
paternal meth self-administration on psychostimulant self-administration in male and female offspring (F1) and
grand-offspring (F2). Intriguingly, our preliminary results indicate that meth and cocaine produce opposite
effects on psychostimulant reinforcing efficacy in male offspring. In contrast to our prior results with cocaine,
preliminary data indicate that paternal meth self-administration results in increased self-administration of, and
motivation for, this psychostimulant selectively in male offspring. Drug naïve F1 rats will be used to generate
an F2 generation, where the acquisition, maintenance and reinforcing efficacy of meth will be assessed just as
in F1 offspring. In Specific Aim 2 we will assess epigenetic changes in sperm through which paternal
psychostimulant self-administration may influence the behavior of offspring. Potential transgenerational
cocaine- and meth-induced epigenetic alterations (small noncoding RNAs and DNA methylation) in sperm will
be evaluated. Finally, genome-wide assessments of psychostimulant transgenerational effects have not yet
been performed on neurons in the nucleus accumbens, a brain region that plays a critical role in modulating
psychostimulant-induced behaviors. The experiments in Specific Aim 3 are designed to interrogate the
landscape of accessible chromatin and gene expression by coupling single-nuclei ATAC-seq and single-nuclei
RNA-seq analyses in the accumbens of experimentally naive meth-sired, cocaine-sired and saline-sired rats.
Collectively, the experiments described in this application will use state-of-the-art cellular, molecular and
behavioral methodologies to examine epigenetic mechanisms whereby psychostimulant-associated
information can be transmitted from sires to offspring and grand-offspring. These cross-generational studies
represent a novel strategy to identify transcripts related to risk or protective factors for psychostimulant self-
administration, which will illuminate new targets for therapeutic development.

Public health relevance
Narrative A growing body of evidence indicates that environmental information can be inherited, which suggests that changes in the mammalian germline can act as a trans-generational carrier of environmental information. Here, we describe a rat model developed in order to delineate heritable behavioral characteristics resulting from paternal self-administration of the psychostimulants cocaine and methamphetamine. The experiments described in this application will use state-of-the-art molecular and behavioral methodologies to examine epigenetic mechanisms whereby psychostimulant-associated information can be transmitted from sires to offspring and grand-offspring.